Mechanisms of wildfire smoke toxicity and susceptibility involving extracellular vesicles in humans

PROJECT SUMMARY/ABSTRACT
Wildfires continue to adversely impact public health in the United States and across the world, with increasing
prevalence of wildfires due to climate change. Evidence demonstrates that wildfire smoke is associated with
asthma exacerbation, decreased lung function, and altered immune responses, in addition to other pulmonary
health outcomes. However, the molecular mechanisms driving wildfire health effects, including those that
underly susceptibility of asthmatics, remain understudied. We have evidence that extraceullar vesicles (EVs),
an emerging mechanism of toxicity, likely play significant roles in mediating the health effects of wildfire smoke.
These changes have been observed alongside alterations in proteins associated with the the hypoxia inducible
factor 1 subunit alpha (HIF-1⍺) pathway in the lung, representing a key pathway underlying ashtma
pathophysiology. However, the role of EVs in influencing preexisting disease susceptibility factors to wildfire
smoke exposure health effects remains to be studied. This study is specifically designed to test the novel
hypothesis that canonical HIF-1⍺ pathway proteins will be enhanced in EVs both at baseline in asthmatics and
following wildfire smoke exposure, with inhibition of HIF-1⍺ resulting in attenuation of inflammatory effects. We
will test this hypothesis through two specific aims (SA): SA1 (in vitro) will examine whether EV release and
content associated with activation of the HIF-1⍺ hypoxia pathway differentiate responsivity of epithelial cells
from asthmatics and non-asthmatics to wildfire-relevant biomass smoke condensate and SA2 (in vivo) will
examine whether EV release and content associated with activation of the HIF-1⍺ hypoxia pathway
differentiate responsivity of asthmatics and non-asthmatic human subjects exposed to wildfire-relevant
biomass smoke. To investigate this mechanism in vitro, we will expose differentiated primary human lung cells
from asthmatic and non-asthmatic donors to wildfire-relevant biomass condensate with and without HIF-1⍺
inhibition in SA1. We will then analyze cellular transcriptomic and secreted extracellular vesicle proteomic
profiles to identify significant differences between disease groups and treatment conditions. Leveraging human
clinical samples, we will isolate EVs from induced sputum from human subjects (asthmatic and non-asthmatic)
exposed to biomass smoke and assess EV proteomic signatures from bulk and cell-type-specific EVs in SA2.
In both aims, data will be analyzed using both standard between group statistical tests and advanced
predictive modeling through machine learning to uncover critical mediators of wildfire smoke susceptibility.
Data from the two aims will be integrated to provide highly translational, innovative insight to understand
mechanisms of wildfire smoke health effects, highlighting therapeutic targets and exposure biomarkers to
leverage in the alleviation of wildfire-associated morbidity and mortality.

Public health relevance
PROJECT NARRATIVE Exposure to wildfire smoke is estimated to affect 25 million people in the US alone, with 33,000 deaths per year associated with wildfire smoke worldwide, largely due to pulmonary health effects. The proposed work seeks to understand the role of extracellular vesicles and the HIF-1α pathway in mediating wildfire health effects and susceptibility in the respiratory system using linked human in vitro and in vivo experimental approaches, with a focus on understanding increased susceptibility in asthmatic populations. The results of this work will help uncover mechanisms of wildfire smoke effects, ultimately contributing to efforts aimed at reducing wildfire- associated morbidity and mortality.